Epigenetic regulation of the neuroendocrine axis in brain development and behavior

PROJECT SUMMARY
Lysine methyltransferase 5B (KMT5B) is part of a gene family that modulates the methylation state of histone 4
lysine 20 (H4K20) residues, and H4K20 methylation regulates gene expression by altering chromatin
compaction. Heterozygous disruptive variants in KMT5B have been associated with human
neurodevelopmental disease–specifically, KMT5B has been identified as one of the most mutated genes in
autism spectrum disorder (ASD), a highly prevalent and lifelong condition. Phenotypes reported among KMT5B
patients and in our Kmt5b mouse model suggest that KMT5B may have a role in the epigenetic expression of
the insulin-like growth factor (IGF) family, which includes two members–IGF1 and IGF2. These hormones can
be expressed in an endocrine (circulating) or paracrine (local) fashion and have been strongly linked to autism.
We hypothesize that KMT5B regulates the expression of the IGF genes driving the primary
neurodevelopmental phenotypes observed. We will test our central hypothesis and, thereby, accomplish the
overall objective of this project through three specific aims. First, we will specify the role that KMT5B plays in
paracrine IGF production (i.e., local brain expression) using both constitutive and brain-specific knockout
models. Second, we will define how endocrine IGF expression (i.e., circulating and expressed postnatally by
the liver) changes relative to KMT5B expression over time and how this impacts (1) brain IGF expression and
(2) KMT5B-linked behavioral phenotypes. We will compare the results of these two aims to identify whether
IGF1 and IGF2 are differentially or similarly regulated by KMT5B and whether rescue can be achieved by
targeting either system. Finally, we will use a combination of ATAC seq and RNA seq to identify cell types
where KMT5B regulates the expression of IGFs and whether these effects can be therapeutically rescued. Our
results will increase our understanding of how KMT5B interacts with the IGF axis, how IGFs are epigenetically
regulated, and how IGF1 and IGF2 are regulated in different tissues over time. We expect the outcomes of this
study to define the contribution of KMT5B to autism clinical features while illuminating novel drug targets for the
treatment of this clinical population.

Public health relevance
PROJECT NARRATIVE Disruptive variation in lysine methyltransferase 5B (KMT5B) has repeatedly been classified as high impact in autism spectrum disorder (ASD), yet the role that this gene plays in the developing brain is poorly understood. This application will generate novel mouse models to identify how KMT5B epigenetically regulates neuroendocrine factors during development contributing to changes in brain growth and patterning. The proposed studies will significantly advance the study of KMT5B gene regulation beyond our current limitations and will illuminate potential therapeutic targets for ASD.